Clear speech in ALS: Effects of feedback from a novel ASR practice paradigm and practice dosage

PROJECT SUMMARY Dysarthria is a motor speech impairment characterized by sensorimotor abnormalities that affect the movements required for speech, frequently resulting in reduced speech intelligibility and naturalness [1], [2]. Dysarthria often significantly impairs communication, in turn threatening a patient’s participation in daily life activities and quality of life [2]–[7]. However, relatively few treatments for dysarthria exist, and patient access to treatments is often limited by financial and geographic barriers [8]–[10]. Amyotrophic lateral sclerosis (ALS) is a neurodegenerative disease characterized by the progressive loss of upper and lower motor neurons. Nearly all individuals with ALS will at some point experience speech impairment [11], [12], characterized by flaccid, spastic, or mixed flaccid- spastic dysarthria. Given the devastating loss of speech in ALS, there is a critical need for evidence-based treatments to help patients maintain their functional speech. Clear speech, which trains a mode of speech with deliberate enunciation, is a successful dysarthria treatment that globally affects the speech system and intelligibility. However, clear speech training uses subjective feedback from a partner, and its effects on intelligibility in ALS have been understudied. Additionally, although increased practice amount has been associated with positive motor learning outcomes in people with unimpaired motor function [13], [69], there is a dearth of research into the effects of single-session practice dosage on impaired limb [57] and motor speech function [10], [14]. This study investigates a novel method for providing feedback using noise-augmented automatic speech recognition to automatically and objectively facilitate clear speech treatment in healthy participants and participants with bulbar ALS. It also examines the effects of single-session practice dosage on learning a clear mode of speaking. Preliminary results support both nASR and increased practice dosage for facilitating clear speech.

Public health relevance
PROJECT NARRATIVE This research investigates a novel, automated ASR-based paradigm for training a clear mode of speech in healthy adults and individuals with amyotrophic lateral sclerosis (ALS). It also examines the effects of practice dosage on clear speech learning in people with ALS. The findings of this research will pave the way for more accessible and time-efficient clear speech treatment for ALS dysarthria, as well as better defined practice guidelines for dysarthria treatment.